MULTICENTER, PLACEBO CONTROLLED TRIAL OF MELATONIN FOR SLEEP DISTURBANCE

The purpose of this study is to determine the effectiveness and safety of melatonin administration in decreasing nosturnal activity and improving sleep in patients with AD and frequent nosturnal awakening.